Circuit Mechanisms of Retrospective Memory-Linking

Project Summary
The central goal of this proposal is to investigate the circuit mechanisms of memory linking, specifically
how aversive memories retrospectively update and link to past neutral memories during post-encoding offline
periods to influence future behavior, such as avoiding dangerous situations. Memories are encoded in a sparse
neural ensemble during learning and then stabilized by offline reactivation that occurs primarily during sleep.
We predict that hippocampal ensemble reactivation during sharp-wave ripples (SWRs) stabilizes recent
memories and integrates recent experiences with past memories. We will experimentally test these predictions
by recording and manipulating ensemble activity along the dorsoventral hippocampus during the offline period
when memories are being stabilized and integrated across time.
We will test the hypothesis that a strong aversive experience leads to ensemble reactivation of both a
recent aversive memory and a past neutral memory during SWRs in the offline period, thus linking the two
memories. Importantly, we will assess how the magnitude of the aversive experience impacts hippocampal
ensemble reactivation of recent and previously encoded memories during SWRs. We will next test the
hypothesis that ensemble reactivation of a past neutral event during SWRs is necessary for memory
integration to occur. We will use immediate-early gene tagging methods to tag specific memory ensembles and
then use our closed-loop optogenetics system to selectively inhibit hippocampal ensemble reactivation during
SWRs to prevent linking. This proposal will provide novel insight into how ensemble reactivation during SWRs
along the dorsoventral hippocampus support integrating memories across time.

Public health relevance
Project Narrative We will investigate how strong aversive events can trigger the reactivation of previous memories encoded days prior, driving memory integration and the transfer of fear to the neutral experience; providing insight into the circuit mechanisms that underlie memory integration across time. We will leverage the combination of in vivo calcium imaging and in vivo electrophysiological recordings in freely behaving mice, ensemble tagging, and closed-loop optogenetics to understand how memories are integrated over time and experience. We hope these data can provide a groundwork for understanding the generalization of fear to neutral stimuli in anxiety- and trauma-related conditions.